Leadership, Planning, and Evaluation

LEADERSHIP, PLANNING, AND EVALUATION
PROJECT SUMMARY/ABSTRACT
UCDCCC Leadership is comprised of highly experienced senior leaders with established track records in
oncology research, patient care, clinical operations, administration, community engagement, outreach, training,
and education. All leaders are committed to achieving the vision and mission of the UCDCCC, centered around
reducing the cancer burden in the catchment area (and beyond) by leveraging the best of UC Davis science. A
highly responsive and integrated organizational structure is in place that facilitates this effort. Planning occurs
in response to evaluation and is considered an iterative process. Progress is re-evaluated continually and
refined and/or redirected in order to maintain the mission of the Center. Input and feedback are obtained from
an External Advisory Committee, a Community Advisory Board, External Consultants, Peer Reviewers, an
Internal Advisory Committee, and many others to ensure appropriate representation from all stakeholders.
Guided by a comprehensive, five-year UCDCCC Strategic Plan, Center leadership has focused on areas that
need strengthening as judged by peer review as well as continually looking for new opportunities to improve
the Center.